The role of monocytes and neutrophils in fungal keratitis

Project summary/abstract
Fusarium, Aspergillus and Candida are important causes of corneal blindness and vision loss in the USA
and worldwide. Preliminary data using a murine models of Aspergillus keratitis show that monocyte depletion
leads to exacerbated corneal disease and impaired fungal killing without affecting neutrophil recruitment to the
corneal stroma. Aim 1 will examine neutrophil activation by Ca++ influx using a novel reporter mouse developed
at UCI and will determine the effect of monocyte depletion on neutrophil pro-inflammatory and fungal killing
activity in infected corneas by multi-photon, intravital microscopy. Preliminary data also identified distinct
neutrophil clusters by single cell RNA sequencing of total CD45+ myeloid cells from infected corneas that
included ICAM-1 expressing neutrophils that were localized at the site of infection in the cornea. FACS isolated
ICAM-1+ neutrophils were more transcriptionally active and produced more cytokines than either ICAM-1- from
WT mice or from ICAM-1-/- mice. Aim 2 will therefore examine the role of ICAM-1+ neutrophils in Fusarium,
Aspergillus and Candida keratitis, and examine the role of the Hv1 proton channel that is elevated in ICAM-1+
neutrophils using Hvcn1-/- mice and novel, highly specific Hv1 inhibitors in fungal keratitis. Aim 3 will examine
the processing and the role of the pore forming proteins Gasdermin D (GSDMD) and GSDME in IL-1β secretion
by neutrophils and in fungal keratitis. We will also examine the effect of small molecule inhibitors of NLRP3,
GSDMD and GSDME. Combined results from these proposed studies will greatly increase our understanding of
the pathogenesis of fungal keratitis and identify potential targets for immune intervention.

Public health relevance
Narrative Pathogenic fungi are leading causes of corneal ulcers, resulting in corneal blindness and vision loss in the USA and worldwide. Risk factors are contact lens associated corneal abrasions and ocular trauma. Once the corneal barriers are compromised, fungal spores can enter the corneal stroma where they germinate, and hyphae penetrate throughout the cornea. Immune cells called neutrophils rapidly infiltrate the cornea to kill these invasive fungi, but these cells also cause tissue damage that contribute to the clinical symptoms associated with this infection. Experiments in this proposal will characterize the molecular events leading to neutrophil mediated fungal killing in corneal infections, and will identify potential molecular targets for therapeutic intervention.